Mosquito extracellular vesicles in malaria parasite killing and immune priming

PROJECT SUMMARY
Malaria has had devastating impacts on human health and economic development throughout the world. Caused
by Plasmodium parasites, the transmission of malaria requires the bite of an infected Anopheles mosquito. This
essential requirement of the mosquito vector to spread disease also creates unique opportunities to interrupt
malaria transmission, where the mosquito immune system is an important determinant of vector competence.
For this reason, the mosquito immune system has garnered significant attention to better understand the immune
mechanisms that limit malaria parasites, with the goal that this knowledge can be applied to strategies to interrupt
the malaria life cycle in its intrinsic mosquito host. Towards this goal, considerable research efforts have
increased our understanding of the mosquito immune system, yet despite these advances, the immune
mechanisms that promote Plasmodium recognition and killing in the mosquito host remain poorly understood.
Herein, we describe novel roles of mosquito extracellular vesicles (EVs) in mosquito immune function, providing
evidence that mosquito EVs have essential roles in the complement-mediated recognition of Plasmodium
ookinetes (Aim 1) and the activation/priming of mosquito immune cells (hemocytes) (Aim 2). Therefore, the
overall objective of this application is to obtain a mechanistic understanding of EV function in the context of the
mosquito immune system by defining the roles of EVs in malaria parasite killing and immune cell
activation/priming. Our outlined experiments will examine the influence of distinct EV (exosome or microvesicle)
biogenesis pathways, define the molecular contents of EVs, and perform single-cell experiments to respectively
delineate the mechanisms by which EVs promote pathogen recognition and cellular immune function in
mosquitoes. The expected outcomes of this proposal will provide fundamental new insights into the previously
unexplored roles of EVs in pathogen recognition and immune cell activation in mosquitoes, such that our results
will have broad impacts on the study of innate immunity and host-pathogen interactions across invertebrate
systems that may inform novel strategies to manipulate mosquito vector competence.

Public health relevance
PROJECT NARRATIVE Mosquitoes of the genus Anopheles are the obligate vector for malaria transmission. With the innate immune system serving as a major determinant of the susceptibility to infection, here we examine previously unexplored roles of mosquito extracellular vesicles in malaria parasite recognition and mosquito immune cell function. The resulting information and its application towards strategies to interrupt malaria transmission in the mosquito vector are relevant to the mission of NIH-NIAID supporting basic research to understand and prevent human disease.